MOLECULAR BIOLOGY &ELECTRONIC STRUCTURES OF METALLO ENZYMES

We intend to run homology searches between DNA and putative amino acid sequences that we have identified from cDNA libraries constructed from pig, chicken, mouse and human gastro-intestinal tracts. We also intend to compare the SV40 tumor antigen to other proteins that are evolutionary or functionally related to T antigen. Large T antigen recent publication previously enclosed.